Regulation of Mitochondrial Remodeling in Adipose Thermogenesis

PROJECT SUMMARY
The global epidemic of obesity poses formidable challenges to human health associated with risks of chronic
diseases such as type 2 diabetes and cardiovascular disease. Obesity is driven by systemic energy surplus
with excessive fat deposition in white adipocytes (WAs). Brown adipocytes (BAs) that are specialized in
dissipating energy through non-shivering thermogenesis and increasing energy expenditure represent a
potential therapeutic target in obesity treatments. However, there is a critical knowledge gap in fully
understanding the molecular mechanisms underlying BA function. Our long-term goal is therefore to explore
the novel molecular regulation of BAs in order to facilitate the development of therapeutic strategies to combat
obesity. By performing quantitative mitochondrial proteomics, we recently identified Family With Sequence
Similarity 210, Member A (FAM210A), an uncharacterized protein, as a critical regulator of thermogenesis in
brown adipose tissue (BAT). Emerging studies reported a potential role of FAM210A in regulating skeletal
muscle growth and pathological cardiac remodeling, however the function of FAM210A in thermogenic BAs is
completely unknown. Using newly developed Fam210a floxed mice, we provided strong preliminary data
supporting an essential physiological role of FAM210A in BAT thermogenesis. We showed that 1) FAM210A is
highly induced by cold and coupled with cold-induced mitochondrial cristae remodeling; 2) Adipocyte-specific
knockout (KO) of Fam210a in mice leads to the whitening of BAT and cold intolerance; 3) Loss of Fam210a
causes metabolic dysfunction of BAT; 4) Fam210a KO induces the depletion of mitochondria and disruption of
cristae architecture. Based on this exciting discovery, the overall goal of this proposed study is to elucidate the
cellular and molecular mechanisms by which FAM210A functions in BAs to regulate thermogenesis, and
investigate the physiological role of adipose FAM210A in systemic metabolism. To achieve this goal, we
propose three specific aims. In Aim 1, using mice and cells with inducible deletion of Fam210a in adipocytes,
we will evaluate the regulatory role of FAM210A in mitochondrial metabolism, synthesis, and degradation in
BAs in vivo and in vitro. Employing high-resolution three-dimensional imaging systems, we will dissect the
function of FAM210A in controlling cold-induced cristae membrane remodeling. In Aim 2, we will define the
molecular mechanisms through which FAM210A regulates mitochondrial homeostasis and cristae remodeling
in BAs via the identification and characterization of interacting protein partners that enable FAM210A’s
regulation of cristae-shaping protein. In Aim 3, we will utilize our unique loss- and gain-of-function mouse
models to test whether FAM210A is required and sufficient to increase energy expenditure and systemic
metabolism so as to ameliorate diet-induced obesity and metabolic dysfunction. Upon completion of the
proposed studies, we expect to establish the functional role of FAM210A as a novel regulator of mitochondrial
dynamics and BA thermogenesis, thus identifying a new potential therapeutic target for the obesity epidemic.

Public health relevance
PROJECT NARRATIVE Brown adipocytes consume nutrient substrates to produce heat and increase energy expenditure, representing a potential therapeutic target to counteract human obesity. Mitochondria are central metabolic hubs and dynamically remodel their subcellular networks and membrane architectures to meet distinct metabolic demands. This proposal will elucidate the role of a novel mitochondrial inner membrane protein FAM210A in the regulation of mitochondrial cristae remodeling and brown adipocyte thermogenesis, and thus unravel an important signaling pathway that integrates mitochondrial biology into metabolic disease.